ANCHR Admin Core

PROJECT SUMMARY/ABSTRACT – Admin Core
The Alaska Native Center for Health Research (ANCHR) Administrative Core is designed to ensure the
success of the overall phase 1 Center at the Alaska Native Tribal Health Consortium (ANTHC). The overall
goals of the ANCHR are to develop a cadre of investigators in Alaska engaged in research to address health
disparities in the Alaska Native population; expand the capacity for health disparities research in Alaska; and
encourage the recruitment of Alaska Native investigators into health disparities research careers at ANTHC
and other organizations in Alaska. The ANCHR consists of multiple components, including a Research Core
and three individual research projects, as well as the Administrative Core. An Advisory Committee will oversee
the ANCHR, including a diverse group of internal and external experts with a spectrum of interests that align
with our Center’s priorities and values. Dr. Thomas is responsible for overseeing the Center as PI, and the
Administrative Core is led by Dr. Ferucci. The specific aims of the Administrative Core are to: 1) Provide
scientific, administrative, and fiscal support and oversight to all components of the Center; 2) Develop and
implement comprehensive training to build the research skills and knowledge essential for the success of
current and potential research project leads (RPLs), mentors, and the Center’s research community; 3)
Coordinate with the Advisory Committee to obtain regular input on the Center, including at least biannual
review of the Center's progress, guidance on recruitment of new RPLs, and review and selection of
replacement research projects; and 4) Evaluate and monitor all Center activities, including RPL development
and mentoring, according to the proposed timeline and evaluation plan. Our long-term goal is to strengthen
ANTHC and Alaska’s research capacity to address health disparities among Alaska Native people, ultimately
to improve the health of the population in alignment with ANTHC’s vision that Alaska Native people are the
healthiest people in the world. The proposed ANCHR has the potential to significantly improve the capacity of
ANTHC and other organizations to conduct research that will improve the health of Alaska Native people and
reduce health disparities in Alaska. Having a tribal health organization lead this Center is innovative and makes
the ANCHR well-poised to address health disparities in a culturally informed manner.